Gulf Regional Area Stroke Programs Regional Coordinating Center Supplement

Our center for 30 years has been a leader in clinical trials testing new treatments for stroke and brain
hemorrhage. In this application, we aim to continue serving as a leading regional coordinating center
(RCC) in StrokeNet and have assembled a well-organized group of connected clinical sites linked by
a history of productive collaboration and led by a multidisciplinary and ethnically diverse team. In
Specific Aim 1, we intend to continue leading a RCC consisting of multidisciplinary teams to conduct
clinical trials testing novel stroke therapies in acute stroke, stroke prevention, and stroke recovery.
The UTHealth RCC will conduct clinical trials within a network of inter-connected sites throughout
Texas, Oklahoma, and Louisiana, involving both adult and pediatric patients with attention to the
recruitment of minorities and women. In specific Aim 2, we will continue to provide expertise and
leadership for the design of novel trials and propose trials testing new stroke therapies in acute
stroke, stroke prevention, and stroke recovery. We will also provide translational expertise for the
development of new stroke therapies from bench to bedside and for the development and testing of
novel biomarkers. In specific Aim 3, we will continue to provide a career enhancement program
within our network for clinician-scientists with high potential for independent research careers in
stroke.

Public health relevance
Stroke is the leading cause of adult disability. New treatments are urgently needed to treat, prevent and promote recovery from stroke. We aim to continue to serve as a regional coordinating center in StrokeNet and conduct clinical trials in a regional network consisting of the hub at UTHealth in Houston and spoke stroke centers throughout Texas, Oklahoma, and Louisiana. Our consortium provides stroke care to an incredibly diverse patient population in the South Central United States and has broad, multidisciplinary expertise in clinical trials for acute stroke, stroke prevention, and stroke recovery.